Integrating Pragmatic Comparative Effectiveness Research into a Tertiary Pain Management Center

Project Summary:
Chronic pain is a major healthcare problem with an annual cost of above $600 billion. The quality of data available
for treatments of chronic pain is not optimal. Generalizability of explanatory randomized controlled trial data is
problematic as these trials exclude up to 90% of patients: leaving out real-world patients with serious medical
and psychological comorbidities. Pragmatic trials embedded in patient care compare effectiveness of currently
used treatments in real-world application leading to findings that generalize to broader range of patients.
The changes in clinical practice and workflow necessary to integrate this type of research within patient care
present pragmatic challenges. In this research, my overall objective is to overcome these challenges using an
open-source learning health care system – CHOIR – developed by my mentor at the Stanford Pain Management
Center. CHOIR is currently used to track patients’ clinical trajectory and treatment response across multiple
academic sites resulting in over 25 publications characterizing chronic pain. Through our pilot studies, we have
already developed a point-of-care randomization for CHOIR that facilitates integration of research and patient
care by allowing the physicians to randomize patients during clinic visits. We have already demonstrated
feasibility of the randomization and data collection platform in two ongoing pilot pragmatic clinical trials.
We are proposing to better integrate pragmatic research within our clinical practice through conducting a
randomized comparative effectiveness trial in 450 patients with chronic pain comparing effectiveness of anti-
convulsants and anti-depressants (two most commonly used classes of medications for treatment of chronic
pain). We will use the data available in CHOIR as well as the real-world data generated from this clinical trial to
build, validate and test a model to predict what clinical characteristics can predict response to either of these
classes of medications.
The proposed study is the first step to use flexible point-of-care randomization to compare effectiveness of
different treatments in different subgroups of patients whenever equipoise exists. Our prediction model will guide
decision making process of clinicians choosing between these medications based on clinical characteristics of
individual patients.
Dr. Salmasi is a physician-scientist with clinical training in Pain Medicine as well as academic training in Clinical
Research and Epidemiology. The detailed career development and research plan presented in this application
will provide the required resources and mentorship for him to become an independent R01-funded expert in two
domains critical to his long-term career goals: (1) advanced clinical trial design and conduct; and (2) advanced
statistics and machine learning.

Public health relevance
Project Narrative Chronic pain is a major healthcare problem with annual cost of above $600 billion in the United States; generalizability of available evidence for treatment of chronic pain (mostly from traditional explanatory randomized controlled trial data) is problematic as these trials exclude up to 90% of patients: leaving out real- world patients with serious medical and psychological comorbidities. We will perform a pragmatic randomized comparative effectiveness trial using our point-of-care randomization. We will then use the data from this trial to build a model predicting the response to anti-convulsants and anti-depressants to develop a platform for precision health: predicting how to choose the best medication for each patient with chronic pain.